Advancing Research in Health Literacy

DESCRIPTION (provided by applicant): Advancing Research in Health Literacy The National Institutes of Health (NIH) has defined health literacy as the "degree to which individuals have the capacity to obtain, process and understand basic health information and services needed to make appropriate health decisions." Unfortunately, fully 22% of US adults have only basic and an additional 14% have below basic health literacy. The relationship between limited literacy and adverse health outcomes has been well documented, and seminal reports about the "problem of health literacy" have been issued by the Institute of Medicine, Agency for Healthcare Research and Quality, American Medical Association, and Joint Commission on the Accreditation of Hospital Organizations among others. Each of these reports advocates further research to develop an effective response within health care systems to address the problem and research in health literacy has begun to flourish. An important next step to cultivate this emerging research field is to create a national professional interdisciplinary home for investigators dedicated to health literacy research. Currently no such venue exists. In this grant application we propose to deliver a second annual conference along a multi-year trajectory dedicated to the promotion of the field of health literacy research. The Institute of Medicine Health Literacy Round Table will provide meeting space and support dissemination via their Web site and by publishing proceedings of the meetings with the National Academies Press. This annual meeting will be designed to provide a venue to focus attention on health literacy research, emphasizing two important sub- themes each year. In year two the sub-themes will be health disparities and patient safety. The meeting will serve as an incubator for young investigators and will encourage a cross-disciplinary exchange of knowledge and collaboration. We aim to create an environment in which controversial topics within the research community can be openly discussed. Paasche-Orlow, M: Advancing Research in Health Literacy The relationship between limited health literacy and adverse health outcomes has been well documented, and seminal reports about the "problem of health literacy" have been issued by the Institute of Medicine, Agency for Healthcare Research and Quality, American Medical Association, and Joint Commission on the Accreditation of Hospital Organizations among others. An important next step to cultivate this emerging research field is to create a national professional interdisciplinary home for investigators dedicated to health literacy research. In this grant application we propose to deliver the second in a series of annual conferences dedicated to promoting the field of health literacy research.

Public health relevance
Project Narrative: Paasche-Orlow, M: Advancing Research in Health Literacy The relationship between limited health literacy and adverse health outcomes has been well documented, and seminal reports about the "problem of health literacy" have been issued by the Institute of Medicine, Agency for Healthcare Research and Quality, American Medical Association, and Joint Commission on the Accreditation of Hospital Organizations among others. An important next step to cultivate this emerging research field is to create a national professional interdisciplinary home for investigators dedicated to health literacy research. In this grant application we propose to deliver the second in a series of annual conferences dedicated to promoting the field of health literacy research.